A novel signaling mechanism for LRP5

Project Summary / Abstract:
Cancer is a leading cause of death, but recent emergence of immunotherapies including the immune
checkpoint inhibitors has offered promising new cancer treatment options. It is also evident that tumor
immunity is highly complex and incompletely understood. The better understanding of tumor immune
regulation may lead to identification of additional targets for cancer immunomodulatory therapy. In this study
we will investigate the mechanism by which the cell surface receptor protein LRP5 regulates NK cell activities
and tumor immunity. In our preliminary studies, we found that loss of LRP5 led to increased activation of NK
cells independently of β-catenin stabilization despite LRP5 is involved in β-catenin regulation in other cells.
Thus, we hypothesize that LRP5 regulates NK activation via previously uncharacterized mechanisms.
Because genetic inactivation of LRP5 in NK cells suppresses tumor progression accompanied with enhanced
NK activities in mice, this new mechanism is potentially of important clinical implications. Our preliminary
results suggest that LRP5 may function as a fatty acid transporter leading to regulation of mTROC1 activity. In
this application, we will carry out comprehensive in vitro and in vivo investigations to characterize this new
mechanism for LRP5 and to determine the roles of this new mechanism in NK biology and tumor surveillance.

Public health relevance
Project Narrative: Immune system is capable of suppressing cancer formation, but is often held back by tumor cells and environmental factors such as diets through immune inhibitors. We potentially identify an immune cell surface receptor for such an inhibitor and is investigating its mechanism of actions and therapeutic potential in mouse models.